GENETIC CONTROL OF MUTATION IN DROSOPHILA

This project is designed to determine the relationship between DNA repair, chromosome structure and mutagenesis in Drosophila melanogaster. A mutation that increases the mutation frequency (a mutator) has been identified and characterized. This mutator greatly reduces the efficacy of a repair pathway for x-ray induced chromosome breaks, thereby allowing a previously undescribed repair pathway to be observed. By this newly identified repair pathway individual broken chromosome ends are "healed," allowing the recovery of terminal deletions. The distribution of chromosome breaks that can be healed has been examined at several levels. (1) The mutator acts only in the female germline, not in males or somatic cells. (2) Breaks can be recovered anywhere in the euchromatin. (3) The mutator increases the recovery of breaks in the heterochromatin, but the breaks are not recovered as terminal deletions. Rather, they are rearrangements similar to the rearrangements from wild-type females. Thus, while the mutator itself does not have differential effects on euchromatin and heterochromatin, the healing process may be specific to euchromatin. (4) The breakpoints of the terminal deletions are distributed randomly, suggesting that specific DNA sequences are not required for the healing process to occur. (5) DNA sequences are being lost from the deficient chromosomes, suggesting that the neotelomeres on the broken ends are not as effective as the original telomeres and that the process of replicating chromosome ends involves loss and replacement of DNA sequences. The terminal restriction fragments of several of these deletions have been cloned. We plan to sequence the DNA of each fragment in order to compare it with the sequence of known telomeres. We are also developing a rapid assay for the mutator to facilitate insertional mutagenesis and transposon tagging.